The Future of Families and Child Wellbeing Third Generation Children’s Study

ABSTRACT
Intergenerational transmission of inequalities in economic and social wellbeing, including health, in the United
States has been well documented and shown to account for a substantial portion of contemporary disparities
by SES and race and ethnicity in these domains. Yet, due to a paucity of population-based longitudinal data on
family contexts, parenting, and child development across multiple generations, knowledge of the extent to
which these factors may be key mechanisms for intergenerational transmission of inequalities is limited. The
Future of (formerly Fragile) Families and Child Wellbeing Study (FF) is the only ongoing population-based birth
cohort study in the U.S. to currently follow three generations of family members. FF follows the parents (first
generation; G1) of initial birth cohort children (G2; born 1998-2000) and the G2 children (now young adults).
Survey and biological data are now being collected on all children born to G2 sample members (G3) as soon
as possible after their birth and will be collected on G2s at age 27. Data span economic, social, environmental,
and biological factors for each generation within a large and diverse national sample. The proposed study will
expand FF to include data at age 5 for all (G3) children born to G2 women. The project aims to: (1) Collect
data on family/caregiving context, parenting and grandparenting behaviors, and child health, socioemotional
development, achievement (cognition), and executive function for all G3 children born to female G2
respondents as they reach age 5; (2) Prepare all data and accompanying documentation to be publicly
available to the research community and fully linkable to all other FF data sources within 1 year of the end of
the award period; (3) Produce a comprehensive guide for implementing virtual assessments of children and
families in the context of a large-scale national study with specific attention to logistical considerations,
response rates, potential challenges (connectivity and quality therein, household distractions, child attention
and comprehension), and lessons learned, both overall and for particular subgroups of families; and (4)
Conduct preliminary analyses of intergenerational correlations of family context/caregiving environment,
economic resources, parenting behaviors, and child development among disadvantaged families. These data
will support novel and important studies of intergenerational transmission of family context, economic
resources, parenting behaviors, and child development; whether associations of family context, economic
resources, and parenting behaviors with child development are consistent or differ across generations; and
whether there is heterogeneity in these patterns by population characteristics. They will also (eventually)
support epigenetic analyses via DNA-based, sociodemographic, and environmental information on three
generations, including prenatal, perinatal, and early childhood data on G2 and G3. As such, FF, with the
inclusion of G3 early childhood assessments, holds unlimited potential to support novel and innovative multi-
generational research to inform public health and social policy.

Public health relevance
PROJECT NARRATIVE This project—the Future of Families and Child Wellbeing (FF) Third Generation Children’s Study—will collect data on the third generation of the FF study. We will collect information on family/caregiving context, parenting and grandparenting behaviors, and child development for all children born to female members of the original birth cohort as these children reach age 5. The data will facilitate novel and important analyses of intergenerational transmission of parenting behaviors, relationships within families, child development, and gene*environment influences on social and economic wellbeing, including health.